Training Program in NeuroHIV (TPNH)

Project Summary/Abstract
This is a new application for an Institutional Training Grant in the basic and clinical aspects of
Neurological Disorders caused by HIV, better known as HIV-associated neurocognitive disorders
(HAND). The Training Program in NeuroHIV (TPNH) is requesting support for 4 advanced
predoctoral students who will be trained in research on how HIV causes neural injury by faculty
actively participating in the Neuroscience and Immunology programs at Georgetown University.
The purpose of this training program is to prepare scientists to investigate molecular and cellular
mechanisms of neurodegenerative processes as well as the immunological responses triggered
by HIV. Our goal is to train researchers on the basic science aspect of developing
neurotherapeutics and/or treatment strategies to reduce the neuronal and glial impairments that
result from HIV infection of the brain. An experienced and well-funded group of 22 faculty
members with a wide range of research interests and expertise in CNS function,
neurodegeneration, virology and immunology will participate in the Ph.D. training program. Most
students will enter graduate school through the Georgetown University Interdisciplinary Program
in Neuroscience (IPN). In the first year they will take course work and rotate through the
laboratories of potential mentors. In the second year, those interested in the TPNH will take
specifically relevant courses dealing with neurodegenerative disorders, immunology, and
immunopathogenesis of HIV infection, as well as extended integrative reasoning and statistical
literacy training, and professional development training (i.e., grant writing and presentation skills).
In the second year of graduate school, students will formally apply to the TPNH with the outline
of a thesis research proposal approved by a potential mentor or co-mentors from the
IPN/Immunology Training Faculty. Thesis research will start after the completion of the Ph.D.
program’s qualifying exam. In their third and fourth years, trainees will participate in training
sessions with clinician-scientists to provide the necessary experience in basic and clinical science
that is key to the understanding of HAND from bench to therapeutics. Trainees will report results
from their research in yearly student seminars, presentations at national meetings, and as
publications in peer-reviewed journals. With respect to public health, this program will create a
core of neuroscientists trained for research and/or management of research programs, through
which new and more effective treatments for HAND and related neuro-immuno-degenerative
disorders will be developed.

Public health relevance
Project Narrative This research training program is focused on the scientific and professional development of advanced predoctoral thesis students in the area of neuronal degeneration caused by Human Immunodeficiency Virus (HIV). Through didactic coursework, laboratory research, career development training, this program will create a core of scientists who will contribute to the understanding, treatment and prevention of HIV-associated neuronal disorders.